IDENTIFY Study: Natural History of Maternal Neoplasia

Dr. Rajagopal was transitioned into the role of PI after the departure of Dr. Annunziata from NIH. Over 90 patients have been recruited to the study to date with at least 1 year of follow up; the trial continues to actively recruit patients. Anticipated initial results (of clinical NIPT testing and correspondence with lab and imaging for malignancy ) are expected to be reported within 2023, but are not yet available given the ongoing recruitment for the study. https://classic.clinicaltrials.gov/ct2/show/NCT04049604